Improving drug safety for pregnant women by delivering current and authoritative information via mobile devices

Project(Summary(/(Abstract( ! An!estimated!40,000!infants!delivered!annually!in!the!United!States!are!born!with!birth!defects!caused!by!the!use!of! medication!during!pregnancy.!!Since!the!peak!prevalence!of!some!diseases,!such!as!hypertension,!autoimmune!disease,! and!depression,!occurs!during!the!childbearing!years,!it!is!not!surprising!that!medication!use!during!pregnancy!is! common,!with!nine!out!of!ten!pregnant!women!in!the!United!States!taking!at!least!one!medication!to!treat!a!medical! condition.!!Although!recent!advances!in!technology!have!increased!access!to!health!care!information,!evidence-based! information!related!to!the!use!of!medications!during!pregnancy!can!be!difficult!to!find.!!Even!so,!much!of!the! information!that!is!available!is!inadequate!when!it!comes!to!prescribing!for!the!individual!patient,!or!it!is!not!easily! understood!or!evaluated!by!healthcare!providers!(HCPs)!who!lack!specialized!training!in!teratology.!!As!the!Center!for! Disease!Control!&!Prevention!notes,!a!few!databases!exist!that!provide!expert!review!and!interpretation!of!the!available! scientific!data!regarding!the!adverse!effects!of!medications!on!the!fetus,!but!these!resources!are!generally!available!by! subscription!only!and!thus!not!widely!available!to!HCPs!or!their!patients.!!As!a!result,!these!databases!are! “underutilized.”!!This!dilemma!ultimately!impacts!two!vulnerable!patient!populations!—!pregnant!women!and!their! unborn!children.! ! To!address!this!dilemma,!RightAnswer!(http://www.rightanswer.com)!and!the!TERIS!team!at!the!University!of! Washington!have!collaborated!to!develop!a!specialized!mobile!application!that!presents!the!relevant!medication! information!in!a!format!that!is!both!easily!readable!and!searchable!in!novel!ways!relevant!to!the!end!users!knowledge! level.!!In!Phase!I!of!this!project,!167!HCPs!that!care!for!pregnant!women!were!surveyed!to!better!understand!their! current!practices!and!information!needs.!!Based!on!these!findings,!a!prototype!mobile!app!was!designed!that! consolidated!drug!information!across!multiple!sources!to!create!a!single!repository!that!included!patient!handouts!and! information!about!breastfeeding,!dosage,!and!alternative!medications.!!An!interface!was!created!to!allow!users!to! navigate!between!concise!and!detailed!summaries!of!the!research!findings.!!The!prototype!was!evaluated!by!22!HCPs! who!found!the!information!presented!to!be!valuable!and!the!app!easy!to!use.!! ! Using!what!was!learned!in!Phase!I,!the!Phase!II!plan!will!focus!on!two!goals:!!1)!continuing!to!improve!the!organization! and!presentation!of!data!to!support!diverse!querying!of!medical!options!and!2)!testing!mobile!app!models!on!a!large! scale!and!expanding!the!user!base!through!commercial!development.!!The!data!collected!in!Phase!I!will!provide! additional!insights!for!Phase!II!development!regarding!critical!data!for!different!clinical!settings!so!that!alternative!forms! of!delivery!can!be!explored,!including!import!into!existing!pharmacy!or!electronic!medical!record!systems!or!pre-loading! data!on!mobile!devices!for!environments!where!network!access!may!be!unavailable.!

Public health relevance
Project Narrative The SBIR project "Improving drug safety for pregnant women by delivering current and authoritative information via mobile devices" will deliver new information dissemination technologies that can reduce drug-induced birth defects and mothers' fears and anxiety about taking medications, when needed, during pregnancy. Health care professionals will use these tools to identify medications and their low- risk alternatives and use their novel information displays to increase a mother's understanding about prescription medications during pregnancy.